Instrumentation Module

Instrumentation - Project Summary
The VRC Instrumentation Core Module supports the design and construction of specialized laboratory
instrumentation. It supports a machine shop, electronics shop, and their associated personnel. The module
provides design consultation, construction of precision mechanical and electronic apparatus, modifications to
commercial instruments to meet specialized vision research needs, and instrument repair and maintenance.
The module has been used heavily by VRC Participating Investigators over the past 5 years, and we expect
that this will continue.